Annual Retreat of the International Society for Environmental Epidemiology

ABSTRACT
The International Society for Environmental Epidemiology (ISEE) is the preeminent scientific society focused on
relationships between environmental agents and human health. The annual conference provides a critical forum
for the exchange of ideas and development of potential solutions to pressing environmental health issues of
regional, national, and global significance. It is regularly attended by prominent epidemiologists from academic,
industrial, and governmental institutions from around the world. As one of the most important international forums
for the presentation of human health research related to air and water pollution, the built environment, and
ecosystems supporting food production, it provides a unique opportunity for environmental epidemiologists,
regulators, and public health professionals to present their work, cultivate new collaborations, and develop
solutions to emerging environmental health issues. Finally, it serves an important training, education, and
networking opportunity for junior investigators and investigators from developing countries. Over the next three
years, the ISEE annual conference is excited to continue focusing on the effects of environmental exposures on
human health, while drawing attention to and addressing climate-related health effects and environmental health
disparities while promoting equity and inclusivity. Upcoming meetings include: 1) the 35th meeting in Kaohsiung,
Taiwan (September 16-21, 2013), with the theme of Connecting the East and the West, One Health in One
Planet; 2) the 36th in Santiago, Chile (September 1-5, 2024), with the theme of Addressing Challenges in
Environmental Health, Justice, and Development; &, 3) the 37th in Atlanta, Georgia, USA (August 17-24, 2025),
with the overall theme of Environmental Health Equity Across the Globe. The three-and-a-half-day annual
meeting offers interdisciplinary examination of new research and methods that are of profound significance to
the field of environmental epidemiology. The conference facilitates the exchange of ideas and information
between epidemiological investigators and public health practitioners from around the world. The upcoming
annual conferences will increase the presence of ISEE in Asia and South America, where environmental
exposures are rife, but routinely understudied. Scholarships will be provided to distinguished experts, young
investigators, students, and promising scientists from the US and developing countries, with an emphasis on
those who are underrepresented minorities or from disadvantaged groups. In turn, this will enhance and diversify
the global development of environmental health work forces and foster collaborations and information exchange
both nationally and internationally.

Public health relevance
NARRATIVE The ISEE annual conference plays a vital role in facilitating dialogue among leading environmental epidemiologists. The conference is the most prominent and comprehensive international gathering of environmental epidemiologists and related environmental health professionals from academia, government, and public health organizations. It provides a forum for discussion, critical review, collaboration, and education concerning environmental agents with the ultimate goal of ameliorating their public health impacts.